Validation of the Pathomechanics and Biology of a Novel Pre-Clinical Rabbit Model for Hip Pre-Osteoarthritis

PROJECT SUMMARY
Osteoarthritis (OA) is a worldwide chronic joint disease that causes pain and disability, and limits daily activity.
Hip OA is the second most common disease after knee OA. Currently, total hip replacement (THR) is the
treatment of choice for advanced hip OA. Given that life expectancy is longer, and we have not found a cure for
OA, it is predicted that THR cases in the United States will increase to more than 1.4 million cases per year by
2040 resulting in a tremendous cost for the healthcare system. Hip Femoracetabular Impingement (FAI) is the
leading cause of hip osteoarthritis in the young adult hip population. While the number of surgical procedures to
treat hip FAI has grown exponentially in the past decade, there is still a 10-25% failure rate following surgical
treatment, with progressive deterioration of the joint leading to OA. Surgeries have outpaced the true
understanding of the disease resulting in failures rates around 15%, where patients still progress to OA following
surgical intervention. Therefore, there is a need to study the mechanisms involved in initiating OA upon FAI and
address this scientific gap. Without a validated animal model, our ability to discover the mechanisms of disease
progression is limited. With the goal of having a low-cost and easy to reproduce translational animal model, our
group has developed a small animal model of femoral head deformity that results in hip OA. Given 1) that FAI
and its progression to hip OA stems from a mechanically induced repetitive injury and 2) the mechanical
differences between quadrupedal and bipedal species, it is necessary to validate this model to human FAI
mechanically and biologically. The goal of this proposal is to confirm that the experimentally induced femoral
head hip deformity is a validated model to human FAI, both mechanically and biologically. For this we
will: i) Determine differences in the mechanical behavior of the hip joint cartilage 1) before and after
experimentally induced femoral head deformity in a rabbit model of hip FAI and 2) compare these changes to
those seen in human hip FAI and ii) Investigate expression of proven human key molecular players in the
progression of hip OA secondary to FAI in cartilage samples from the established rabbit femoral head deformity
model. This project has the potential to tremendously impact the field, as it will allow, for the first time, to have a
low cost, small translational animal model of hip FAI and hip OA. This model could be used as a platform to
understand in-depth the mechanisms of hip OA, test interventions and translate our discoveries to patient care.

Public health relevance
PROJECT NARRATIVE Femoroacetabular impingement (FAI) is the leading cause of hip Osteoarthritis (OA). There is minimal information on the molecular and the pathomechanical response of the articular cartilage to hip FAI and there has not been an established animal model that could help us understand better human FAI and hip OA. This proposal aims to validate a rabbit model of hip femoral head deformity to human hip FAI.